Administrative Core

The Southwest Environmental Health Sciences Center (SWEHSC) Administrative Core (AC) provides the
necessary infrastructure to integrate the leadership, organization, and strategic vision of the SWEHSC. In
providing overarching support, the AC advances the SWEHSC mission to facilitate and implement innovative
research and community engagement aimed at understanding the mechanisms underlying environmental health
(EHS) risks and disease among people living in arid environments undergoing climate change by coordinating
SWEHSC research, training, and community engagement efforts. Accordingly, the AC coordinates and
integrates Center activities, attracts new investigators with outstanding EHS capabilities through the Pilot
Projects Program, develops the capacity of EHS researchers through career development opportunities,
facilitates interdisciplinary EHS activities, and promotes cutting-edge research opportunities. The AC also
promotes the translation of findings to improve medical and public health interventions for the unique Southwest
populations and environment through the Cellular Imaging, Omics, and Integrated Health Sciences Facility
Cores. Likewise, the AC facilitates statewide, national, and international SWESHC initiatives, coordinates
community outreach to Native American, Latinx, and rural populations, and ensures the integration of the Facility
Cores (FCs) and the efforts and activities of the three Research Focus Groups, which center on environmental
exposures experienced by populations residing in the desert Southwest, lung disease resulting from
environmental exposures, and uncovering the mechanisms underlying adaptive responses to environmental
stress. The ultimate goals of the SWEHSC AC are to 1) support new and emerging research initiatives that align
with the Center vision and mission; 2) ensure that FCs provide the cutting-edge technologies needed by Center
members in an efficient and cost-effective manner that fully integrates all Center resources; 3) increase the
number and enhance the career development of investigators, particularly new investigators, studying EHS
issues; 4) assist the CEC in public outreach efforts to Native American, Latinx, and rural populations in the
Southwest to encourage their participation in EHS research and community-driven projects; and 5) increase the
Center's research grant base. Broadly, the AC plays an essential role and provides the necessary infrastructure
to ensure the success of SWEHSC.